EFFECT OF LOCAL RADIATION ON LYMPHOCYTE POPULATION IN MEN AND WOMEN WITH CANCER

This research will look at the effects of radiation therapy on lymphocyte kinetics in patients irradiated for the treatment of cancer.